Metabolomics Core

CORE 3 PROJECT SUMMARY
METABOLISM CORE
The Metabolism Core (Core #3) supports the metabolomics and proteomics experiments designed by program
project grant (PPG) investigators as integral parts of their proposed research. These large-scale molecular
data analysis strategies are used by all four projects in this PPG, which provides synergistic linkage points,
facilitated by Core #3, across projects for cross identification of metabolites and proteins that play important
roles in lung cancer biology and immunology. Core #3 members have extensive experience in cancer
metabolism, metabolomics, proteomics, liquid chromatography-mass spectrometry, gas chromatography-mass
spectrometry, collaboration with investigators, collaboration with data scientists (including members of Core
#4), and customer service. These efforts will contribute to projects from inception to completion (i.e. from
hypothesis to publication). Core #3 will support optimization of experimental design for mass spectrometry-
based omics (Aim 1), which includes implementation of previously published strategies and development of
novel methods for sample preparation, separations including gas and liquid chromatography, and mass
spectrometry to support the experiments required by PPG investigators. Datasets will be acquired with
untargeted metabolomics, discovery proteomics, analysis of post-translational modifications, and targeted
assay development for metabolites and proteins utilizing state-of-the-art separations and mass spectrometry
equipment at Moffitt Cancer Center (Aim 2). Core #3 members will contribute to quality assurance/quality
control for data acquired for each project and collaborate with PPG investigators and other PPG Cores to
produce high quality datasets and develop data analysis strategies to maximize availability and usage of omics
data across PPG Projects (Aim 3). In summary, Core #3 will make a significant contribution to the proposed
research by elucidating molecular mechanisms underlying lung tumor biology and tumor-immune cell
interactions, which may ultimately reveal potential biomarkers and novel treatment targets to be further
investigated in functional studies proposed by the PPG Projects.

Public health relevance
CORE 3 PROJECT NARRATIVE METABOLISM CORE The Metabolism Core (Core #3) provides services to support the projects and is a central and key component of this program project grant (PPG). The goal of Core #3 is to provide experience and expertise to support experimental design, sample preparation, data acquisition, quality control, collaboration with Core #4 for analysis, and assistance with biological interpretation of results to support the research proposed by the PPG project investigators. The faculty and staff involved in Core #3 apply complementary metabolomics and proteomics approaches to address complex hypotheses in preclinical models (e.g. cell lines, xenografts, and genetically engineered mouse models) as well as human tumors and actively collaborate to maximize the availability and utility of the results.